Optimization of a Self-Adjuvanting Particle System for Delivering Respiratory Syncytial Virus Prefusion Protein

In the US, RSV infects nearly 100% of children, and total associated hospital charges are estimated at
approximately $2.5 billion dollars. Infants are most susceptible to severe RSV-related disease in the first six
months of life. During this time, infants mount poorly protective antibody-mediated immunity on their own upon
RSV infection or vaccination. Rather they veer toward Th2-type responses, which can cause disease- or vaccine-
enhanced severity upon re-infection, and subsequent wheezing throughout childhood and into their teens. In
recent years, promising maternal RSV vaccine candidates have progressed to clinical trials, but the window of
protection to the infant remains limited to the half-life of the maternally-derived antibody (~1 month) or moderately
longer if the mother is breast feeding. An RSV vaccine that protects infants beyond the first month of life or
ameliorates the course of their respiratory disease, will (i) reduce the frequency of infant hospitalizations, (ii)
improve the quality of life for infants, families, communities, and populations, and (iii) lessen disease burden on
the US economy.
In this multiple PI project, we seek to optimize and characterize a nanoparticle-based intranasal RSV vaccine
platform with intrinsic adjuvant properties. The biodegradable biotin-nanoparticle system (referred to as bNP)
functions as an antigen carrier and immune activator. Coupling antigen delivery and adjuvant properties into a
single physical entity will enhance the capacity to overcome the inherent immunosuppressive environment of
mucosal tissues. The particle system has a tunable design in which the dose of the antigen can be varied without
remanufacturing. To ensure a Th-1 type response, we will use a variant RSV prefusion protein (preF) engineered
to lock in the native conformation as the cargo antigen.
We hypothesize that preF sterically stabilized on bNP (preF-bNP) will activate antigen-presenting cells to induce
important correlates of protection, including RSV-specific Th1-dominant T cell response, CD8 resident memory T
cells, and neutralizing antibody. Three specific aims are proposed. In Aim 1 we will optimize display of preF on
bNP and capacity of the formulation to activate antigen presenting cells. In Aim 2 we will determine preF-bNP
uptake kinetics into antigen presenting cells and preF-bNP-induced immunity in vivo, including resident memory T
cells. In Aim 3 we will establish the safety and efficacy of intranasal preF-bNP in an RSV mouse model.
Successful completion of the studies will lead pave the way for advancing a novel RSV vaccine formulation for
generating safe and protective RSV immunity in young children.

Public health relevance
This proposal aims to optimize and characterize a novel vaccine formulation designed to safely improve the immune response to respiratory syncytial virus (RSV), a disease that causes significant morbidity and mortality in young children and for which no preventable vaccine exists. This novel nanoparticle vaccine formulation uses a biodegradable platform with inherent adjuvant properties to deliver a potent RSV antigen that is more readily taken up by dendritic cells, which are responsible for inducing antibody production and antiviral T cell responses. The tunable nature of the system allows one to tailor the antigen dose and adjuvant potency to balance efficacy and safety profiles, and in this proposal, will be optimized in an established mouse model of RSV infection.